PURIFICATION OF BRAIN PROTEINASES AND IDENTIFICATION OF THEIR CLEAVAGE PRODUCTS

Calcium activated neutral proteinase (CANP II) from bovine CNS myelin was isolated and purified by my collaborator, Dr. Banik. This enzyme was used to digest human myelin basic protein, component 1 (HBP-1) because the sequence of this protein is known. CANP digests were separated on HPLC into pooled fractions. N- and C-terminal sequences of these pools yielded eleven cleavage sties in HBP-1. The major site was Val(94)-Thr(95). Dr. Banik has also isolated and purified multicatalytic proteinase complex (MPC) from bovine brain. MPC also digests HBP-1 but at a much slower rate. Human myelin basic protein (HBP) occurs in multiple forms. Three of these isoforms have been highly purified - HBP-1 (unmodified BP), 17.2kDa HBP (missing residues 106-116) and HBP 3pT98 (phosphorylated on Thr(98)). When compared with circular dichroism (CD) studies done on HBP-1, the CD studies of 17.2kDa HBP showed about 9% increase in ordered structure and those of HBP 3pT98 about a 12% increase. Both modifications of HBP-1, the delection of residues 106-116 and the addition of a single phosphate promoted secondary structure, probably an increase of beta-structure.